Upgrade and operational improvements to the SouthEastern Biosafety Laboratory, Alabama, Birmingham (SEBLAB)

Project Summary/Abstract: This project will modernize and upgrade the SouthEastern Biosafety Laboratory, Alabama Birmingham (SEBLAB), as well as greatly expand the research capabilities available for studies of newly emerging infectious diseases, and other agents of significant concern to human health. The scope of the proposed project includes three specific aims: 1. Infrastructure update 2. Infrastructure correction 3. Research equipment SPECIFIC AIM 1: Natural wear and tear on continuously running equipment since 2009 is significant. Items under this specific aim will replace worn, discontinued or obsolete equipment, upgrading to the latest technology and improving energy efficiency. SPECIFIC AIM 2: Correcting problems only realized during operation, unforeseen during design and construction. The issues needing correction include dynamic air balancing to ensure proper directional airflow, electrical outlet switch out to better suit sensitive research equipment, and modernizing select biosafety equipment to optimize facility operations. SPECIFIC AIM 3: The purchase of high-end research equipment the current users of SEBLAB desire, but cannot acquire by other means (BD Symphony S6 cell sorter, MILabs µCTUHROIFLT). State of the art equipment such as these are critical to continuing high impact science in SEBLAB. Upon completion, this project will achieve the following: 1. Updated facility infrastructure that is both functional and energy efficient, so SEBLAB can continue its contribution to biodefence and emerging infectious diseases research. 2. Optimization of the systems in SEBLAB for current use and expected needs of the facility. 3. Providing research staff with the best tools available, both enhancing research capabilities, and expanding translational impact of the research in SEBLAB.

Public health relevance
SPECIFIC AIMS: The University of Alabama at Birmingham (UAB) is proud to host to one of the NIH-sponsored Regional Biocontainment Laboratories (RBL). UAB constructed the Southeastern Biosafety Laboratory, Alabama, Birmingham (SEBLAB) (Figure 1) with the 1UC6AI058599-01/3UC6AI058599-01S1/S2 award from the National Institutes of Allergy and Infectious Diseases (NIAID) and institutional funds. SEBLAB became operational in 2009, and since then has not received additional federal funds for infrastructure upkeep, changes or significant research instrumentation acquisition. Therefore, this funding opportunity is very much welcomed and greatly appreciated. The funds will go toward three specific aims: 1. Infrastructure update 2. Infrastructure correction 3. Research equipment SPECIFIC AIM 1: Replacement of worn and/or dated equipment. SEBLAB’s mechanical systems have been in constant operation since 2009. It is never “off.” Therefore, natural wear and tear on continuously running equipment is significant. In addition, it is an excellent opportunity to upgrade to the latest technology and increase energy efficiency. SPECIFIC AIM 2: Correction of issues that are problematic during operation but unforeseen during design and construction. The most significant issue under this specific aim is the air balance of the building. Currently, although it is possible to isolate a room or a suite of rooms from the HVAC system, it disrupts the air balance to the entire building, requires work cessation, and threatens airflow reversal from the isolated area. The need to isolate an area could be from a spill, general room decontamination, etc., so an airflow reversal is unacceptable and requires correction. There are also issues with electrical outlets in the animal area, and Class II B2 biosafety cabinets (BSC) ducting. SPECIFIC AIM 3: Purchase of high-end research equipment to facilitate and augment research of current users of SEBLAB (BD Symphony S6 cell sorter, MILabs µCTUHROIFLT). While similar representatives of both pieces of equipment exist on campus, those areas cannot accommodate animals or samples infected with risk group 3 agents. State of the art equipment such as these are critical to continuing high impact science in SEBLAB. Upon completion, this project will achieve the following: 1. Updates to facility infrastructure that are both functional and energy efficient so SEBLAB can continue its contribution to biodefense and emerging infectious diseases research in an environmentally conscientious manner. 2. Optimization of the systems in SEBLAB for current use and expected needs of the facility. 3. Providing research staff with the best equipment available, both enhancing research capabilities, and expanding translational impact of the research in SEBLAB. SIGNIFICANCE AND NEED: The Southeastern Biosafety Laboratory, Alabama, Birmingham’s (SEBLAB) mechanical systems have been in constant operation since 2009. It does go through an annual shutdown for routine maintenance, but only in a rolling fashion, which means the building is never “off.” It is constantly ready in a redundancy “N+1” state. Therefore, natural wear and tear on continuously running equipment is significant. As such, the proposed equipment changes in specific aims 1 and 2 impact the building and as a whole, rather than just a few areas. Equipment in need of replacement because of wear and tear and/or obsolescence include: 1) Six high plume exhaust fans (Figure 2), 2) three Heat Recovery Unit drives and starters with programing, 3) two Bioquell VHP room sterilization systems, and 4) six autoclave control panels. Given the infrastructure and containment demands on the building, the energy load is also high, so other upgrades focus on sustainability and energy efficiency. They include converting the five existing air-handling units to newer fan wall units, and upgrading to LED lighting and digitally controlled valves instead of pneumatic. It is also important to correct problematic issues discovered during regular operation, but were unforeseen during design and construction. The most significant issue is disrupted airflow balance when an area is isolated from the rest of the building. In that situation the exhaust air does not or cannot adjust appropriately to support the correct airflow to all the other areas of the building. Therefore, although it is possible to isolate a room or a suite of rooms from the HVAC system, because of the airflow disruption, it requires work cessation throughout the building and threatens airflow reversal from the isolated area. The need to isolate an area could be from a spill, or general room decontamination, etc., so an airflow reversal is unacceptable and requires correction, which we will accomplish with a combination of: Added programing of the HVAC controls, replacing single fans in the supply air with variable speed fan arrays, installing variable speed exhaust fans, and new heat recovery unit drives and starters. The animal areas are not spray down areas, but all outlets in the building were originally installed as GFCI (though not required by code), and can interfere with research equipment. They need replacing. Also in the animal area, the Class II B2 biosafety cabinets do not route to the HEPA filter banks for the suite. Instead, they have their own independent exhaust duct, (Figure 3) and serve as the only exhaust for the room. This causes the HEPA filters to get loaded quickly, which in turn affects the building air pressure balance. To correct this problem the ducts from the five Class II B2 cabinets will have an inline bag-in/ bag-out HEPA filter installed, along with decontamination ports and bubble-tight dampers on either end. In conjunction, new Class II A2 BSCs will replace the existing cabinets, which are not adaptable to any other configuration. Finally, the grant funds will be applied to the purchase of high-end research equipment the current users of SEBLAB desire but cannot acquire by other means (BD Symphony S6 cell sorter, MILabs µCTUHROIFLT). While similar pieces of equipment already exist on campus, they are in areas that cannot accommodate risk group 3 agent infected animals or samples. State of the art equipment such as these are critical to continuing high impact science in SEBLAB. Specifically, both pieces of equipment will get immediate use on studies involving SARS-CoV-2 and tuberculosis. They will greatly expand research options and decrease response time for work on other agents including newly emerging infectious diseases. They will serve all SEBLAB users, and be available, after proper decontamination, to run non-infectious samples on campus when time permits. DESCRIPTION OF THE FACILITY: The project proposed consists of upgrade and replacement of various mechanical systems and support equipment, as well as the purchase of two pieces of high-end research equipment, for the SEBLAB, located at the corner of 19th Street and 9th Avenue South in Birmingham, Alabama. Construction of SEBLAB completed in 2008, and the building was operational in 2009. SEBLAB has approximately 43,700 gross square feet of space, with 10,700 net square feet of usable laboratory, animal housing and support space. There are no proposed changes to the physical structure of the building; only equipment replacement, purchase, and some ductwork modification. Since 2009, and up through 2019, SEBLAB supported the research of nine University of Alabama at Birmingham (UAB) investigators (including some affiliated work with the Southern Research Institute) with funding of $39M. At the end of 2019, the list of active and pending users included seven investigators with funding of $5.2M. Since the beginning of the COVID-19 pandemic, nearly all the focus of existing investigators shifted to SARS-CoV-2 research and active investigators increased to 12. Besides SARS-CoV-2 research, SEBLAB also supports research on tuberculosis, equine encephalitis viruses (Eastern, Western and Venezuelan Equine Encephalitis), Chikungunya virus, Avian Influenza viruses, and SARS-CoV-1. The institutional commitment to SEBLAB is clear from the continued investment in its annual operating costs of approximately $820,000 per year ($320k for operations, and $500k for utilities). The University of Alabama at Birmingham understands and accepts the responsibility to maintain this space and support systems to ensure that this research facility continues to meet the needs of our funded investigators and research partners. When these upgrades are complete, the University commits to funding for staff, operating and maintenance costs, and other expenses that are necessary for the effective use of the facility to support our broad biomedical research community. In addition to financial support, SEBLAB is operated from a team approach, including members from Environmental Health and Safety, Occupational Medicine, Facilities/ Maintenance, Physical Security, UAB Police, Information Technology and the Animal Resources Program. UAB also provides ongoing support of the building’s operation, conducting preventative maintenance and needed repairs. However, the systems are now getting to the point where costly but essential equipment is reaching end of life (e.g., exhaust fans, autoclave controls, room decontamination equipment, etc.) and there are insufficient institutional funds to upgrade and/or replace those critical components. Therefore, this funding opportunity could not have come at a better time to aid UAB in its continued commitment of support for SEBLAB. The funds will ensure SEBLAB continues safe operation for the foreseeable future. JUSTIFICATION OF THE PROJECT: Beyond the upgrade and replacement of essential components reaching their end of life (e.g., exhaust fans, pneumatic valves, heat recovery unit drives and starters, autoclave control panels, and Bioquell VHP room decontamination equipment), the funds will go to correcting some issues causing problems in the operation of the building. The most important problem this project will correct is the inability of the building to rebalance airflow automatically from changes to rooms supplied. From time to time, rooms need to be isolated for decontamination. The SEBLAB systems can isolate rooms and spaces without too much difficulty. However, the problem becomes the airflow balance. When spaces are isolated, the exhaust flow rate remains constant, which means the missing volume pulls from other locations. This situation disrupts the directional airflow pattern, which is so critical to containment. Some rooms become more negative making it difficult to open doors, etc. In other spaces, particularly the isolated space, the airflow threatens to reverse, since the room is essentially a reservoir of air for the exhaust. Out of an abundance of caution, all work is required to stop in the building for room or space decontamination. This is very disruptive and hinders the ability to decontaminate spaces in a prompt fashion. The improvements proposed herein will resolve these issues. New variable speed exhaust fans with controls upgrades and new variable speed fan arrays in the supply air Air Handling Units (AHUs) will allow air flows to be adjusted to maintain proper air pressure relationships. Another significant problem is in the animal areas of the facility. In those areas, there are five Class II B2 biosafety cabinets (BSC). The BSCs serve as the only exhaust in the rooms where they are located (Figure 4). To maintain pressure relationships, the cabinets cannot adjust from their original configuration with an 8- inch sash height. Unfortunately, the caging that is used in SEBLAB is just over 8- inches high when fully assembled. So, in order to get any cage in and out of the BSC, the sash must be raised and lowered. Trying to work with the animals in 8- inch-high cages through an 8-inch-high sash is challenging at best. This proposal includes five new Class II A2 BSCs that will replace the existing five Class II B2 cabinets and an inline bag-in/ bag-out HEPA filter installed in the duct. Each of those rooms will then have their own exhaust installed that no longer relies on the BSC as the sole source of exhaust for the room. New variable volume exhaust fans will enable the building to maintain the appropriate pressure relationships. Discovery of the final problem for correction was relatively recent, with the increased use of SEBLAB after the start of the COVID-19 pandemic. The possibility of spray or washing down the animal holding areas required the installation of all Ground Fault Current Interrupter (GFCI) outlets. Unfortunately, some research equipment has trouble with GFCI outlets. No spray down of the animal areas occurs, nor is it desired since there are no room drains, or other method of dealing with the water generated from such an activity. Therefore, the project includes replacement of all GFCI outlets in the animal areas where code lines allows, e.g., further than six feet from a water source. Reverting to non-GFCI not shown). outlets will reduce electrical interruptions. As mentioned before, SEBLAB is energy intensive, so the grant funds will enable the possibility of changing to more energy efficient systems. Sustainability is a key component of all projects at UAB. There are two upgrades in this grant application that will address energy savings and sustainability. The first is upgrading the lights to LED, which will reduce power requirements by approximately 24.3 kW annually, saving about $20,000 in annual operating expenses. The second is to convert the supply AHUs to fan wall systems. These systems are energy efficient because they only utilize the number of fans required for the conditions. They also add a level of redundancy by allowing the other fans to run, in case of a failure of one of the fans in the fan array. So while the current AHUs always have a backup (N+1), the fan wall adds an internal redundancy within each air- handling unit. Finally, this grant opens the possibility for access of truly exceptional research equipment for our investigators. The placement of a cell sorter in the SEBLAB will enable users to purify populations of cells obtained from cultures or animals based on cell surface attributes. (Figure 5 – room 145A2) Purified cells, bacteria or exosomes can then be used in functional or molecular assays, in cell culture, or in animals. The Symphony S6 cell sorter configured with four lasers (blue, red, green, and violet) allows users to simultaneously sort up to six populations of cells based on 22 fluorescence parameters. The S6 cell sorter includes multiple nozzle sizes (70um 85um 100um, 130um), which allows users to sort cells of different sizes. It also has highly sensitive detectors that can discriminate particles as small as bacteria and exosomes. The S6 is equipped with an Automatic Cell Disposition Unit, which allows users to sort defined numbers (as few as a single cell) of cells/bacteria/particles into 384-well and 96-well plates for cloning or other types of single cell analyses. Importantly for its operation in the SEBLAB, the S6 sorter is integrated into a Baker biosafety cabinet to ensure aerosol containment and operator protection. Currently the only option for SEBLAB users with infected samples is inactivation and/or fixation so that they can leave for use on machines outside of containment. This severely limits the research and advances available to SEBLAB investigators. The S6 will remedy this problem. Another equipment request is for a live animal imaging system, the MILabs µCTUHROIFLT. (Figure 5 – room 143B) Currently SEBLAB does not have live animal imaging capability. This instrument will fulfill broad and long-term objectives including the conduct of simultaneous functional and anatomic imaging over a wide array of biological and preclinical applications related to infectious diseases and its pathophysiological consequences. The µCTUHROIFLT system allows for precise anatomic information in 3D by ultra-high resolution (as low as 4 voxel) computed tomography (CT) that is coupled with functional imaging with a large number of agents (fluorescent and bioluminescent) in the same animal at the same time, providing broad applicability to biological applications including evaluation of the dissemination of infections and the pathophysiology of the infected host. Co-localized functional and anatomic information provides superior understanding of disease pathogenesis and therapeutic response, accelerating research progress with techniques not yet available to the SEBLAB. This equipment will significantly enhance a breadth of ongoing research using state of the art imaging by opening up a wealth of sophisticated multi-modality protocols that provide precise anatomic information in 3D coupled with functional imaging using a large number of agents (fluorescent, bioluminescent, etc.), providing broad biological applicability and the ability to respond to emerging organisms. The capability of obtaining such precise and accurate information in vivo longitudinally will ultimately improve reproducibility and reduce the number of animals required for each study – this is particularly important when working with infected animals and situations where rapid results are imperative or the disease course needs to be established. This will provide the only radiographic capability currently in the facility, providing a powerful tool for those working with SARS-CoV-2/COVID-19 (World Health Organization recognized as important for SARS- CoV-2 animal models), in addition to other infectious disorders evaluated in SEBLAB environment spanning multiple disease areas, including respiratory, microbiological, and environmental applications. MODERNIZATION PLAN: The exhaust system is arguably the most important component of an BSL/ ABSL-3 facility. The high plume exhaust fans ensure that the building maintains the appropriate pressure relationships, and that any harmful gasses and vapors are effectively displaced away from the roofing system, and any personnel in the vicinity. The high plume exhaust fans at SEBLAB are original to the facility. This grant will replace those fans with brand new reliable high plume exhaust fans. The new fans will pose no new demand on the building systems. Replacement of the high plume exhaust fans has its challenges, but the fans will be replaced in pairs, with four (4) units running at all times to minimize the impact to the facility. The air handling units (AHUs) at SEBLAB are currently single-fan constant-volume fans in each unit. The requests in this grant application propose to replace the single fans in each unit with a fan wall (fan array) system with variable-speed fans. This upgrade will allow for energy savings, as the individual fan speeds can be reduced. This fan array system at each AHU will also provide much needed redundancy by allowing the individual fans to be replaced in the event of failure. Other fans may continue to operate if a single fan stops running. The only challenge associated with this refurbishment is the stoppage of the AHU that is being converted. However, the SEBLAB facility currently has a redundant AHU at all times, so as long as the fans are replaced one unit at a time, the facility operation will not experience interruption. SEBLAB was originally fitted with pneumatic control valve actuators. This is outdated technology that needs to be replaced with new electronic actuators tied into a direct digital control (DDC) system. This upgrade will allow for the automated control of the building valves. Replacement of the actuators will require a shut-down of building systems. This work will need to be performed in shifts that minimize the interruption of research at SEBLAB. New upgrades to the building controls (Siemens) will accommodate an improvement in building pressure relationships. The new controls, coupled with new supply and exhaust fan upgrades (fan wall systems) will allow for improved control of building pressure relationships. This will resolve the issue of building pressure relationship changes (positive/ negative) when specific areas of the building need to be cleaned or decontaminated. Upgrades to the Class II B2 Biosafety cabinets (BSCs) at SEBLAB will contribute to the improvement of air balancing in the building. The building currently relies on the five existing Class II B2 BSCs to exhaust their respective rooms. The proposed improvements will result in new and improved BSCs, as well as new exhaust vents for each room, exclusive of the BSCs. New exhaust HEPA filtration will be installed before the existing BSCs are taken offline in each room. Lighting upgrades are included to maximize energy savings. When SEBLAB came online in 2009, LED bulbs were not prevalent in new construction practices. SEBLAB is currently fitted with fluorescent tubes (bulbs). This grant will allow all bulbs (approx. 1,800 bulbs in 600 fixtures) to be replaced with new LED tubes. This upgrade will offer a significant savings of approximately $20,000 in annual operating expense. This upgrade will not pose any major interruption to the facility’s operations, as the bulbs will be replaced one room at a time. This project does not propose replacing the six existing passthrough autoclaves in SEBLAB, because they received all service recommended by the manufacturer, which extends the warranty for the pressure vessels out to 2023. However, pressure vessels typically last well over 40 years, so there is no concern about them at this time. Nevertheless, the service areas housing the sterilizer controls is hot and humid, which is not the best environment for computer equipment. As such the controls need replacing, furthermore they are obsolete and no longer available for repairs. The newest PSS500 control board will replace the existing controls, and will improve sterilization cycle options. In addition, two new autoclave rack shelves are in the quote, which brings the two bulk autoclave racks already owned to fully operation and utility for processing bulk materials. Currently shelves were consolidated to a single autoclave rack, but volumes of bulk materials needing autoclave are increasing so it is important to get both autoclave racks back to full operation. Lastly, this proposal includes extensive Test & Balance of the new supply and exhaust, as well as commissioning of the building systems to ensure that SEBLAB is operating at optimum efficiency. This testing and commissioning will require shut-downs of specific areas of the building, that will be coordinated prior to the work being performed. PROJECT MANAGEMENT AND INSTITUTIONAL COMMITMENT: The vision of UAB is to be “One university inspiring and empowering the creation of knowledge that changes the world.” The idea of UAB as a leader is strong and engrained in the hearts of all faculty and staff working at this great institution. With this in mind, it is clear that the commitment of UAB to provide and support SEBLAB is substantial and will continue indefinitely. These not only include financial commitments, but the commitment of personnel resources, administrative support, faculty hires, space and infrastructure support. The management of SEBLAB has always been a group effort, and this structure will continue to ensure that this project comes in on time and on budget. The PI, Dr. Erik Dohm, is the Director of SEBLAB, and has extensive experience in leadership roles within the biocontainment community. He served as the Laboratory Animal subgroup leader since the NIAID sponsored 2nd Annual NBL-RBL Network Meeting in 2009 up through two years ago. As it pertains to the operation of SEBLAB, a diverse team (most included as key personnel on this proposal) joins him. Dr. Moustafa Awaden is the operations manager of SEBLAB, and he brings with him extensive biocontainment and infectious disease research experience from around the world. Chad Dunaway represents Environmental Health and Safety and is very familiar with the day-to-day running of SEBLAB. Dale Payton is the Animal Resources Program Facilities and Standards Manager, and joins Richard Watts and Greg Parsons from UAB Facilities to manage the renovation components of the project. Mr. Watts and Mr. Payton are very familiar with the infrastructure and design of SEBLAB, making them the ideal personnel to oversee the renovation portions of the grant. Mr. Parsons, as Chief Facilities Officer at UAB ensures oversight and commitment to quality workmanship and financial stewardship for the University and all contractors working on the project. A SEBLAB Management Team, including Drs. Dohm and Awaden, Mr. Payton and Dunaway, (and others) meet weekly to discuss operations, review procedures and resolve issues as they arise. This team functions well together and represents a broad and diverse range of experience and leadership. Related to the instrumentation, the management team will involve some added oversight to ensure fair and efficient resource scheduling, as well as a system in place to help support ongoing maintenance agreements and consumable replacement. To accomplish this, both pieces of equipment are going into already established institutionally supported cores in the UAB Institutional Research Core Program. The Flow Cytometry Core will incorporate the BD Symphony S6 cell sorter into its portfolio of equipment. Two members of the core have already been through initial training for SEBLAB in anticipation of obtaining flow cytometry equipment for the building. They will need to continue training once the equipment is available, but the plan is for them to operate the equipment for most samples, including non-infectious samples from researchers without a presence in SEBLAB when machine time permits. In that way, we will avoid having to give facility access to large numbers of people, but it opens up the equipment capabilities to the general campus and beyond. Similarly, incorporation of the MILabs µCTUHROIFLT imaging platform into the Small Animal Imaging Shared Facility core will be a great asset to the portfolio. The experienced staff from the Small Animal Imaging Shared Facility will supervise and provide technical expertise for the imaging system. In addition, a research group, Dr. Steven Rowe, already established and working within SEBLAB is familiar with the technology. Several staff from that research group with independent access to SEBLAB are more than capable of running complex scans already. Therefore, while staff from the Small Animal Imaging Shared Facility get trained and proficient with SEBLAB procedures, the equipment will be used and available for use by non-SEBLAB users, as time permits, through arrangement with the Rowe research staff. The Small Animal Imaging Shared Facility staff will ensure allocation of resources to assist new users with imaging applications, and interpretation of images. The combined skills and expertise of the current faculty and staff of the Small Animal Imaging Shared Facility will ensure successful integration of the SEBLAB MILabs µCTUHROIFLT within the current infrastructure.